Thalamic Contributions to Functional Network Abnormalities in Alzheimer's Disease

Project Summary / Abstract
This is an application for a K23 Mentored Patient-Oriented Research Career Development Award for
Dr. Carolyn A. Fredericks. A Clinical Assistant Professor at the Stanford Center for Memory Disorders, Dr.
Fredericks is an early-career clinical researcher whose long-term goal is to establish a multimodal
neuroimaging research program investigating the role of subcortical nuclei in amnestic and atypical
Alzheimer's disease. To accomplish this long-term goal and transition to independence as an investigator, Dr.
Fredericks seeks to meet the following goals during the period of the K award: (1) learning cutting-edge
methods in structural and functional MRI study design and analysis; (2) gaining expertise in the project
management of large clinical studies; (3) deepening her knowledge of the cognitive psychology and
neuroanatomy of memory; (4) improving her knowledge of biostatistics; and (5) building leadership skills and
adding to her understanding of research ethics. To achieve these goals, Dr. Fredericks has the support of a
mentoring team including primary mentor Dr. Anthony Wagner, a psychologist with expertise in the
neuroscience of memory and high-resolution task-based fMRI; co-mentor Dr. Michael Greicius, a behavioral
neurologist with expertise in the neuroimaging of intrinsic connectivity networks in Alzheimer's disease;
consultant Dr. Brian Rutt, a radiologist specializing in high-field (7T) structural MRI; consultants Drs. Vinod
Menon and Manish Saggar, experts in advanced imaging analysis techniques in neuroimaging; and consultant
Dr. Lu Tian, a biostatistician with expertise in longitudinal data analysis.
The proposed research uses a multimodal imaging approach to understand the role of specific thalamic
nuclei in intrinsic connectivity networks in healthy aging, and to characterize structural and functional
abnormalities in these nuclei and networks in Alzheimer's disease. Aim 1 evaluates the relationship between
anterior thalamic volume and specific aspects of memory task performance, both in healthy older individuals
and those with preclinical Alzheimer's disease, and aims to show that lower volumes over time predict worse
memory performance. Aim 2 uses high-resolution task-based MRI to examine how connectivity between
anterior thalamus and other key structures affected in Alzheimer's disease relates to memory task performance
in healthy aging and preclinical Alzheimer's disease. In Aim 3, patients with mild cognitive impairment and two
variants of Alzheimer's disease undergo fMRI scans at rest, and graph theoretic and seed-based analyses are
used to understand the role of thalamic nuclei within functional networks that are abnormal in Alzheimer's
disease. Successful completion of this work could result in the earlier detection and more accurate
classification of people at risk for Alzheimer's disease and in the identification of new promising targets for
treatments.

Public health relevance
Project Narrative Alzheimer's disease is a public health crisis. The proposed work seeks to enable earlier detection and identify new targets for therapy, by using advanced neuroimaging technologies to study structural and functional changes in thalamic nuclei during healthy aging versus Alzheimer's disease.